Research Development Core

RESEARCH DEVELOPMENT CORE
PROJECT SUMMARY
Understanding the complexity of the aging process and its profound effects across all levels of biological
organization will require a strong, interdisciplinary, and diverse supply of talented scientists. The overall goal of
The Jackson Laboratory Nathan Shock Center (JAX NSC) Research Development Core is to provide support
for career development of junior faculty entering the field of basic aging biology or other investigators who wish
to change career direction towards basic aging research. In 2017, the pilot award format was changed from
providing funds awarded to two investigators per year ($50,000 each) to an innovative in-kind program where
experiments were streamlined for awardees enabling more experiments to be performed for a larger number of
investigators within the same budget. During the current funding period, the JAX NSC Research Development
Core competitively awarded funding and resources to aging projects across biological systems that resulted in
new discoveries, research publications and sources of funding, and helped junior awardees to establish their
own independent careers in aging research. Moving forward, these successes will be expanded by providing
targeted funding to exciting projects proposed by investigators new to aging research, and by offering a variety
of research and intellectual resources to support awardees and other aging investigators in their work. The
outstanding institutional resources available at JAX, a premier institution for mouse genetics and systems biology
research, will be leveraged to sustain and grow this foundation of researchers at JAX and within the aging
community. The Specific Aims are: Aim 1. Fund projects for new investigators in aging research using a
competitive pilot award program. Promising investigators new to aging research will be funded through a
competitive process so they can generate the data and gain the expertise necessary to support competitive
funding applications and a transition to a career in aging biology. Aim 2. Provide resources to support pilot
awardees and investigators new to aging research. Access to resources (e.g., aging mice, data, tissues,
phenotype platforms, expertise) will be provided to support pilot awardees and other investigators new to aging
research. The aging mouse cohorts and phenotyping technologies supported by the JAX NSC present a valuable
opportunity for investigators to access material and collect data that might otherwise be prohibitively expensive
or difficult to obtain. Aim 3. Provide mentorship and career development opportunities in aging research.
Investigators new to aging research will be provided with mentorship by JAX NSC researchers and collaborators.
They will also be given opportunities for career development in the aging field via support with the grant writing
process, opportunities to participate in aging meetings, and introductions to potential collaborations within the
broader aging community. The impact of the Research Development Core is that the pool of investigators
devoted to the study of the basic biology of aging will be expanded.